Biochemical Mechanisms of Long-Term Potentiation

DESCRIPTION (provided by applicant): This project focuses on the role of signal transduction mechanisms in hippocampal Long-term Potentiation (LTP) and memory formation. In the most recent Project Period we have been exploring the role of the Mitogen-Activated Protein Kinase (MAPK) family of signal transduction cascades in hippocampal synaptic plasticity and learning, focusing on the mechanisms through which this pathway controls memory-associated gene transcription. We initiated our studies in this area about 15 years ago by determining that the Extracellular-Signal Regulated Kinase (ERK) isoforms of MAPK are necessary for NMDA receptor-dependent LTP in area CA1. We then transitioned to studies in the behaving animal and discovered that ERK is activated in the hippocampus with contextual associative conditioning, and that ERK activation is necessary for fear conditioning and for spatial learning in the Morris water maze. Studies from a wide variety of laboratories have now shown that MAPK signaling is involved in many forms of synaptic plasticity and learning, in essentially every species that has so far been examined including humans. Given the clear importance of understanding the roles and regulation of ERK in synaptic plasticity and learning, for the next Project Period we propose to continue our investigations into the genomic and epigenomic targets of ERK in the hippocampus. We will pursue the following three Specific Aims: 1: To test the hypothesis that the ERK/MSK pathway regulates histone methylation in the hippocampus. 2: To test the hypothesis that alterations in hippocampal histone methylation occur with memory formation and are necessary for long-term memory and LTP. 3: To test the hypothesis that inhibition of histone de-methylation augments memory formation. By focusing on this important new target for the ERK pathway in hippocampus, histone methylation, we will continue to formulate a comprehensive model of ERK involvement in molecular decision-making in synaptic plasticity and memory.

Public health relevance
PUBLIC HEALTH RELEVANCE: The discoveries potentially arising from this Project will be broadly relevant, encompassing mechanisms related to psychiatric disorders, aging, drug addiction, cognition, memory, and learning disabilities. One Aim of the Project specifically involves preclinical studies to evaluate a potential new type of treatment for learning and memory disorders. Narrative: The discoveries potentially arising from this Project will be broadly relevant, encompassing mechanisms related to psychiatric disorders, aging, drug addiction, cognition, memory, and learning disabilities. One Aim of the Project specifically involves preclinical studies to evaluate a potential new type of treatment for learning and memory disorders. __SpecificAimsTextDelimiter__ BIOCHEMICAL MECHANISMS OF LONG-TERM POTENTIATION SPECIFIC AIMS In the last Project Period we and others discovered a new process contributing to synaptic plasticity and memory formation: the regulation of nuclear chromatin structure through histone post-translational modifications. These discoveries by several laboratories ushered in a new era of investigating the roles of epigenetic molecular mechanisms in plasticity and memory, an era which we feel is just beginning. As part of these investigations our studies uncovered two novel targets of ERK MAPK in the CNS: histone acetylation and histone phosphorylation. Thus, during the last Project Period we proposed a new synapse-to-nucleus signaling pathway in the hippocampus that is involved in memory, the ERK-MSK1-Histone phospho-acetylation pathway. This was a significant step forward in what has been a focal point of the Project for the past 15 years, understanding the role of MAPK signaling pathways in controlling gene transcription, synaptic plasticity and memory formation. These discoveries also triggered a new emphasis in the Project on mechanisms regulating gene expression in memory. Interestingly, the discovery of a role for chromatin-modifying molecular mechanisms in memory reprises a unifying theme of the Project - conservation of developmental plasticity and molecular information storage mechanisms to subserve behavioral memory in the adult CNS (1). In the next Project Period we propose to build on these findings, and to focus on the potential roles and regulation of novel chromatin-modifying molecular mechanisms in the hippocampus and in hippocampus- dependent memory formation. Specifically, we will focus on testing our working model that ERK- mediated regulation of histone methylation is involved in synaptic plasticity and memory formation. Thus far as part of this Project we have investigated histone acetylation and phosphorylation in memory formation. The other major post-translational modification of histones that can affect gene transcription is methylation. Histone methylation is typically associated with persisting changes, and this mechanism is a powerful controller of gene readout. Indeed, histone methylation is interesting in part because it was until very recently thought to be irreversible. Also, the concept of a histone code for memory formation (2-6) makes investigating histone methylation intriguing, wherein it might play an important role in molecular encoding of the salience of environmental stimuli and combinatorial control of gene transcription. Histone methylation is a novel transcription-regulating event to consider in the context of memory formation because it can potently suppress gene regulation, and gene repression has not been extensively studied in memory formation. Moreover, mutation of the JARID1C histone demethylase leads to human X-linked mental retardation, directly implicating a role for histone methylation in a human memory disorder (7-9). Finally, mechanisms for controlling histone methylation in general, and in the CNS in particular, are largely uninvestigated and ripe for discovery. Having chosen to focus on a potential role of histone methylation in controlling synaptic plasticity and memory formation, our Specific Aims are therefore: Specific Aim 1: To test the hypothesis that the ERK/MSK pathway regulates histone methylation in the hippocampus. In several studies to date we have determined that ERK and MSK1 regulate histone acetylation and phosphorylation in the hippocampus. For this Aim we will determine whether this same pathway (ERK/MSK) controls histone methylation. We are motivated in these studies by preliminary results wherein we have observed that inhibitors of ERK activation block fear conditioning-associated hippocampal histone methylation. For this Aim we will use predominantly in vitro biochemistry approaches, and we will complement these studies in Aim 2 using in vivo assessments. We will be aided in these studies by the availability of both pharmacologic MEK inhibitors and an MSK1 knockout mouse line that we have on hand. These studies will be particularly relevant for two reasons. First, the signal transduction pathways controlling histone methylation are almost completely uncharacterized for any cell type at this point. Second, these studies will begin to address whether ERK/MSK a central unifying pathway controlling all three main histone modifications, versus the scenario that histone post-translational modifications are controlled by multiple independent pathways in the CNS. Specific Aim 2: To test the hypothesis that alterations in hippocampal histone methylation occur with memory formation and are necessary for long-term memory and LTP. For this Aim we propose to determine whether altered histone methylation occurs with memory formation in vivo using direct biochemical methods, utilizing contextual fear conditioning as our behavioral memory model. We will utilize immunohistochemical and laser capture dissection approaches to define the cell types in which these molecular changes occur. As part of these studies we will extend Aim 1 by addressing whether ERK and MSK1 activity are necessary for training-induced regulation of histone methylation in vivo. In additional studies we will determine if regulation of histone methylation is necessary for memory consolidation in vivo using pharmacologic and gene knockdown approaches to specifically inhibit histone methyltransferase activity. Specific Aim 3: To test the hypothesis that inhibition of histone de-methylation augments memory formation. Discoveries of new mechanisms that underlie memory allow the opportunity to identify potential new routes of therapy for memory disorders. Indeed, in a series of key publications several laboratories have capitalized on the discovery of a role for histone acetylation in memory formation, and provided important proof-of-principle evidence that elevating CNS histone acetylation can improve memory formation (10-27). While Specific Aim 2 will determine if changes in histone methylation occur with and are necessary for long- term memory, these studies will not address whether augmenting histone methylation can also affect memory capacity. We will address this question in Aim 3, wherein we will use virus-mediated knockdown to reduce hippocampal histone demethylase activity and determine the effects of this manipulation on learning and memory in vivo. These studies will provide preliminary proof-of-concept data concerning the potential applicability of histone demethylase inhibitors as memory enhancing agents. In pursuing these three Specific Aims we will investigate a role for chromatin-modifying molecular mechanisms in regulating memory formation at a newly defined locus. We have chosen to investigate histone methylation not only because we have preliminary results indicating its importance, but also because this target defines a logical set of continuing studies that are an outgrowth of our systematic investigation of ERK regulation and targets in the hippocampus. Thus, we are investigating: 1) a novel potential target of ERK in memory, histone methylation, 2) a new potential site of ERK-regulated crosstalk between two established targets of ERK, histone acetylation and phosphorylation, and a novel site, methylation - studies that will have implications for the potential of a histone code operating in memory formation, and 3) an important preclinical drug development opportunity arising from investigating a novel target in the hippocampus, histone de-methylation. By focusing on this novel target in the overall ERK pathway in hippocampus, we will be able to continue to formulate a comprehensive model of ERK involvement in molecular decision-making in plasticity and memory formation.